Neurotoxicity of particulate matter and its interaction with APOE in neurodegeneration

PROJECT SUMMARY/ABSTRACT
Alzheimer's disease (AD) is the most common cause of dementia among elderly and is an apparent public
health challenge in the U.S. as well as many other countries. Despite the extensive research effort on all
aspects of AD, the exact causes of late-onset, sporadic AD remain elusive. Although genetic predispositions
including known risk genes from human genetics studies are playing a prominent role in the pathogenesis and
etiology of AD, recent growing bodies of evidence strongly suggest an emerging role of environmental
contribution, particularly toxic constituents of air pollution including, but not limited to, particulate matter (PM)
and metals, to the progression and onset of AD. Thus, it is critical to investigate how air pollution drives
neurodegeneration and whether AD risk genes modulate its neurotoxicity and neuronal death, as an empirical
example of the gene x environment (GxE) interactions to support the mechanism-based etiology of AD. As
increasing number of studies in humans and animal models have confirmed the pivotal role of currently known
risk genes and exposure to air pollution, independently or in combination, in AD neuropathology and
neurodegeneration, we stay focuses on determining key neurotoxic mechanisms of ambient PM, the most
abundant toxic constituents found in the ambient air, which subsequently leads to accelerated
neurodegeneration and the clinical onset of AD. The overarching objectives of this study are 1) to
comprehensively evaluate neurotoxicity of ambient PM and its environmental risk in a novel mouse model of
late-onset AD, and 2) to identify key genes and mechanisms that determine the sensitivity or resilience to
neuronal death triggered by PM. In this application, we include several innovative tools, such as a novel mouse
model, human iPSC-derived neurons and the CRISPR-based functional genomics, to carefully assess the
neurotoxicity of PM, its risk for developing and exacerbating AD phenotypes, and the GxE interactions, all of
which could be more clinically relevant and applied to broader general population compared to existing findings
from widely used animal models overexpressing familial AD mutations. In our knowledge, proposed in vivo and
in vitro models are the best suited models to simulate and evaluate the environmental contribution to late-onset
AD in humans. Thus, outcomes from this study maintain high translational significances to understand
neurodegenerative mechanisms and the GxE etiology of late-onset AD. Lastly, this proposal is feasible, highly-
significant, and highly-relevant to evaluate the etiology and progression of AD in the context of the GxE
interactions. We believe that the outcomes could have large impact to the field, while accelerating progress
towards understanding the environmental impact on the pathogenesis of AD.

Public health relevance
PROJECT NARRATIVE This application will determine the key neurotoxic mechanisms elicited by the mixture of particulate matter (PM), the major toxic constituent of ambient air pollution, and its toxic interactions with APOE gene in neurons. To achieve this goal, we will utilize highly innovative CRISPR-based functional genomics, human iPSCs and a novel mouse model of late-onset Alzheimer's disease (LOAD). The proposed study is carefully designed to maintain high translational and clinical significance and to simulate chronic exposure to ambient PM relevant to human exposure, in order to assess the contributing risk of PM and to unveil the mechanism-based gene x environment etiology of LOAD.